Peripheral mechanisms of exercise intolerance in HFpEF

Project Summary/Abstract:
The hallmark features of heart failure with preserved ejection fraction (HFpEF) are exercise intolerance and
exertional symptomology. It is now clear that the pathophysiology of exercise intolerance involves multiple
physiological systems in HFpEF with peripheral (‘non-cardiac’) abnormalities having a critical role. Locomotor
muscle afferent feedback reflexes are necessary for the normal locomotor muscle blood flow and ventilatory
responses to exercise in healthy adults. However, these locomotor muscle afferent reflexes appear to be
‘overactive’ with HFpEF impairing locomotor blood flow and exaggerating the ventilatory response. Additionally,
pulmonary system alterations and inspiratory muscle metabolic inefficiency in HFpEF necessitate an
exaggerated inspiratory muscle blood flow demand during exercise. Importantly, HFpEF patients are unable to
meet this exaggerated inspiratory muscle blood flow demand during exercise. This exaggerated deficit between
inspiratory muscle blood flow demand and blood flow response to exercise in HFpEF may predispose them to
exercise intolerance and exertional dyspnea. Our scientific premise is that locomotor and inspiratory muscle
pathophysiologic mechanisms contribute to the well described exercise intolerance and exertional symptoms in
HFpEF patients. The Specific Aims that will be explored in this proposal include: 1) To test if locomotor skeletal
muscle afferent feedback reflexes contribute to the abnormal cardiovascular and ventilatory function during
exercise in HFpEF, and 2) To test if inspiratory muscle training reduces the exaggerated inspiratory muscle blood
flow demand in HFpEF and improves exercise tolerance and exertional symptomology in these patients. Both
Aims are framed with testable hypotheses and clearly associated with the experimental protocol and statistical
analysis plan. Our integrative, highly collaborative research team has the intellectual and technical expertise,
established infrastructure, and clearly demonstrate high feasibility in performing all facets of these studies to
address and interpret the Aims we have proposed. Our proposal addresses an important problem by focusing
on ideas that are a significant departure from current paradigms on exercise intolerance and exertional
symptomology in HFpEF patients. Our preliminary data and review of the rigor of prior research supporting
our Aims provide strong justification for our innovative experimental design, gold standard techniques, and
inspiratory muscle training (an intervention with high clinical utility) to reveal how locomotor and inspiratory
muscle dysfunction impair exercise tolerance and exertional dyspnea in patients with HFpEF. Finally, we have
aligned our scientific premise, aims, and associated hypotheses with the NHLBI Research Priorities and the
current NIH review criteria that emphasizes significance, impact, and innovation for R01 applications.

Public health relevance
Project Narrative Heart failure patients with preserved ejection fraction (HFpEF) exhibit severe exercise limitation and exertional dyspnea and in this context, the central premise of our proposal is that locomotor and inspiratory muscle pathophysiologic mechanisms contribute to these HFpEF symptoms. In this application, we investigate the role the 1) locomotor muscle reflexes have on the abnormal cardiopulmonary responses during exercise in HFpEF patients, and 2) exaggerated inspiratory muscle blood flow demand during exercise (arising from inspiratory muscle inefficiency) have in contributing to exercise intolerance and exertional dyspnea in HFpEF patients. The novel mechanistic questions we have developed combined with the cutting-edge measurements, innovative experimental design, and use of a clinically relevant intervention (i.e., inspiratory muscle training) will provide new targets to intervene on to improve exercise tolerance and exertional symptomology for HFpEF patients.